Peer Recovery Support Services for individuals in Recovery Residences on MOUD

Project Summary/Abstract: The United States is experiencing an unprecedented opioid epidemic.
Medications for opioid use disorder (MOUD), such as methadone, buprenorphine, and extended-release
naltrexone, are the recommended standard of care. There are, however, many treatment barriers to MOUD
adherence and retention that result in high MOUD discontinuation. This elevated MOUD dropout predicts poor
health outcomes including increased opioid use/relapse, overdose, and death. To further compound the
current opioid crisis, there are no established evidence-based interventions that specifically focus on improving
MOUD adherence and retention, and typical strategies used by treatment providers are limited by being clinic-
based. Thus, the goal of this study is to address this gap by developing an intervention that leverages the
impact of two widely used existing recovery support services outside of usual treatment: peer recovery support
services (PRSS) and recovery residences (RRs). The PRSS intervention will include the following components:
coaching, mentoring, education, and other supports delivered by peers uniquely qualified by their lived
experience with substance use disorder. RRs are another critical component of the intervention because they
provide a supportive living environment for persons in recovery. The intervention will be tailored to specifically
promote MOUD adherence. Peers will be embedded within the local provider community, provide assertive
outreach between episodes of care, emphasize continuation in treatment, and emphasize return to care after
treatment dropout and/or relapse. The potential synergistic benefits of combining PRSS and RRs to improve
MOUD retention are considerable, and their impact will be investigated by including both components in the
intervention developed in this proposed research study. The study involves three methodological phases linked
to our specific aims that occur sequentially over 36 months. Phase 1 consists of preparation for the intervention
implementation including building a network of RRs that will be recruitment sites in the pilot RCT, recruiting and
training peer support specialists, conducting focus groups and interviews to gather stakeholder input, and
developing PRSS approaches to promote MOUD retention. We will test the PRSS intervention in (n=5)
individuals recruited from partnering RRs to prepare for Phase 2. Phase 2 consists of conducting the pilot RCT
of the PRSS intervention by randomizing individuals (N=50) on MOUD who reside in partner RRs to either: a
24-week course of the PRSS intervention added to treatment as usual (TAU), or TAU without the PRSS
intervention. Our primary outcome of the RCT is cumulative MOUD retention over the 24-weeks. Finally, phase
3 involves gathering additional qualitative input on PRSS intervention and conducting data analyses to inform
the methodology for a follow-up R01 application. This research trajectory will support NIH’s mission by directly
addressing the low MOUD adherence and retention rates that are exacerbating the devastating effects of the
opioid crisis.

Public health relevance
Project Narrative This research will contribute to fundamental knowledge about the impact of recovery support services on pharmacotherapy retention in opioid use disorder treatment. Specifically, the short-term goal of this project is to develop an efficacious intervention that combines peer recovery support services and recovery residences to enhance retention on medications for opioid use disorder. The long-term public health impact of this research may significantly improve health outcomes for individuals with opioid use disorder and reduce the devastating impact of the ongoing opioid epidemic in the United States including over-dose-related deaths.